The Affordable Care Act: MCV/PCV & Pertussis

DESCRIPTION (provided by applicant): The Minnesota Department of Health (MDH) has been an Emerging Infections Program site since 1995. As the program has matured it has become increasingly complex and difficult to both scientifically and administratively manage all programs and activities. This funding will allow the hiring of an EIP supervisor and a grants manager. MDH has been developing an electronic disease surveillance system which is ready to start including pathogens covered by EIP. In addition, the Public Health Laboratory has is developing a new electronic information management system. Funding will allow hiring of an epidemiologist and a laboratorian to complete development of these systems by testing and assuring interoperability. During the 2009-10 novel H1N1 pandemic there was a huge gap in meeting the need for influenza testing. EIP surveillance plans for a continuation of testing patients hospitalized for influenza, so these funds will allow for surge capacity in this area with the hiring of a laboratorian and purchase of some equipment. Lastly, MDH is applying for funding for the specific project of monitoring healthcare-associated infections among dialysis center patients.

Public health relevance
PATIENT PROTECTION AND AFFORDABLE CARE ACT (PPACA); EMERGING INFECTIONS PROGRAM (EIP); ENHANCING EPIDEMIOLOGY AND LABORATORY CAPACITY (U01) FUNDING OPPORTUNITY NUMBER: RFA-CI-10-003 CATALOG OF FEDERAL DOMESTIC ASSISTANCE NUMBER: 93.521 ACTIVITIES 1, 2, 3 AND 4 MINNESOTA DEPARTMENT OF HEALTH DUNS NUMBER 804887321 AUGUST 27, 2010 TABLE OF CONTENTS Activities 1 Activities 1 and 2: Support of Personnel, and Education/Training....................................1 I. Background and Understanding: Scope of Activities and Infrastructure...................................1 II. Need....................................................................................................................................................3 III. Operational Plan..............................................................................................................................4 IV. Measures of Effectiveness.................................................................................................................4 Activity 3: Information Technology and Exchange.................................................................................5 I. Background and Understanding......................................................................................................5 II. Need....................................................................................................................................................5 III. Operational Plan...............................................................................................................................6 IV. Measures of Effectiveness.................................................................................................................7 Activity 4: Enhancement of General Epidemiology and Laboratory Capacity Related to PCR Testing for Influenza, and Healthcare Associated Infections........................................................9 Activity 4a. PCR Testing for Influenza.....................................................................................................9 I. Background and Understanding......................................................................................................9 II. Need....................................................................................................................................................9 III. Operational Plan...............................................................................................................................9 IV. Measures of Effectiveness..................................................................................................................10 Activity 4 b. Healthcare Associated Infections.......................................................................................11 I. Background and Understanding....................................................................................................11 II. Need..................................................................................................................................................11 III. Operational Plan............................................................................................................................12 IV. Measures of Effectiveness..................................................................................................................12 Activities 1, 2, 3, and 4a./4.b.....................................................................................................................13 V. Human Subjects Issues...................................................................................................................13 VI. Sharing Research Data and Resources .........................................................................................13 VII. List of Attachments...........................................................................................................................13 Activities 1 Activities 1 and 2: Support of Personnel, and Education/Training I. Background and Understanding: Scope of Activities and Infrastructure In 1995, the Minnesota Department of Health (MDH) Acute Disease Investigation and Control Section (ADIC) began as one of the four original EIP sites. We have assessed the impact of emerging infections, emphasized prevention, monitored diseases, and investigated outbreaks. We have trained students, conducted research, and implemented interventions. In the last 15 years we have successfully dealt with the complexities of operating an EIP, including instituting population-based surveillance (including Active Bacterial Core Surveillance [ABCs], FoodNet, Unexplained Deaths [UNEX], influenza, and other site-specific activities), and served as a national site for emerging pathogens. We have been an effective and flexible collaborator with CDC, other EIP sites, and other non-EIP states. We have responded to emerging issues, including variant Creutzfeldt-Jakob disease, intussusception and rotavirus vaccine, SARS, seasonal influenza-related pediatric morbidity and mortality, a resurgence of invasive Haemophilus influenzae type b in young children, and 2009 pandemic H1N1 influenza, and have successfully redirected resources to investigate these issues while still completing routine EIP tasks. We have been involved in a number of multi-state outbreaks, often as the first to detect them. We have followed common ABCs and FoodNet protocols and shared data with CDC. We have promoted PulseNet as an outbreak detection tool and have facilitated pulsed-field gel electrophoresis (PFGE) testing of isolates from other states. We have shared our findings nationally at the Council of State and Territorial Epidemiologists and PulseNet/OutbreakNet meetings. We have shared bacterial isolates, protocols, results, and other materials with other EIP sites, and non-EIP states and institutions. We regularly contribute to EpiX, the MMWR, and the Foodborne Disease Outbreak listserve. We present our findings at national meetings such as American Society of Microbiology, Infectious Diseases Society of America, and the International Conference on Emerging Infectious Diseases. We have led or contributed to multi- state data analyses and presented the findings through many published manuscripts (Attachment 1). We have an excellent relationship with clinical labs. The Public Health Laboratory (PHL) has established the Minnesota Laboratory System (MLS), a statewide network designed to facilitate inter-laboratory communication and collaboration. We also present at, attend meetings, and support the Minnesota Interlaboratory Microbiology Association (MIMA). We have a long-term relationship with infection preventionists (IPs). We have contracted with their organization, APIC-MN, to provide training to its members, specifically on emerging infections and EIP. They provide time during their meetings and space in their newsletter for us to give updates. We have an excellent relationship with the medical community. We are a regular participant and contributor to the weekly Infectious Disease Interhospital Conference. Since 1995 we have co- sponsored and will again in November 2010 hold an annual (16th) statewide Emerging Infections Conference with the University of Minnesota (UM) School of Medicine and the Mayo Clinic. We have a variety of collaborative relationships with health care providers and HMOs. Since 1995 we have conducted an ongoing study of diarrheagenic E. coli in cooperation with HealthPartners, the largest HMO in the state. In 2000, we extended this study to include the St. 1 Cloud Hospital Laboratory, which serves a semi-rural area of the state it also is a site for Clostridium difficile surveillance. We enjoy a strong collaborative relationship with the UM Schools of Public Health and Medicine and serve them as a training center. Several EIP staff have UM adjunct faculty positions. We sponsor a program whereby family practice residents rotate through MDH for exposure and training. The PHL offers a clinical microbiology rotation with emphasis in for students and continues to train public health and hospital-based microbiologists in the use of PFGE. UM and Mayo Clinic pathology residents frequently perform 3-week rotations with PHL and ADIC. M.P.H. students are employed to work on "Team Diarrhea" (performing interviewing and data entry for foodborne illness surveillance), "Emerging Epis" (that does the same for ABCs), "Team Flu", or "Vector Squad". Many of these students use EIP data to complete their thesis projects. Our students have gone on to work at MDH, other state and local health departments, CDC, attend medical school, or enroll in doctorate programs. We also work closely with the UM College of Veterinary Medicine. MDH obtains all S. Typhimurium and S. Newport isolates from the Veterinary Diagnostic Laboratory to study antimicrobial resistance in food animal isolates and compare molecular subtypes with those from humans. MDH maintains a strong relationship with the Minnesota Department of Agriculture (MDA) whose staff purchase meat products and test it for Campylobacter and Salmonella, as part of the Retail Food Study. MDA is also a partner in foodborne outbreak investigations. ADIC and PHL are extensively involved in EIP. Dr. Danila, who has a doctorate in epidemiology, provides oversight of all activities (in-kind support). He is the ADIC Manager and the Deputy State Epidemiologist. He prepares the applications including progress reports, monitors the budgets, supervises the staff, and oversees administrative aspects including IRB submissions. Dr. Lynfield, State Epidemiologist and MDH Medical Director, is board-certified in pediatric infectious diseases and provides overall scientific oversight (in-kind) but has a focus on ABCs, UNEX, influenza, and the healthcare-associated infections projects. Drs. Danila and Lynfield are EIP Principal Investigators. Dr. Lynfield has served as Co-Chair of the EIP Steering Committee for several years. Dr. Smith (in-kind) provides administrative and scientific oversight for FoodNet and vectorborne (including TickNET) and zoonotic disease activities. He is a veterinarian with a doctorate degree in veterinary parasitology and was an Epidemic Intelligence Service officer. Additional staff include Dr. DeVries, a medical epidemiologist and board- certified infectious disease physician with an M.P.H., and Dr. Medus (for FoodNet) who has a doctorate in public health. Ms. Harper, M.S., C.I.C. manages the ADIC Infection Control and Antibiotic Resistance Unit which encompasses healthcare-associated infections (HAI) projects and MRSA. Ms. Harper and Dr. Lynfield serve on the EIP HAI-Community Interface Steering Committee. The PHL has implemented methods to detect and identify emerging pathogens, conduct bacterial serotyping and subtyping, characterize virulence factors, detect antibiotic susceptibility, and maintain a collection of ABCs and FoodNet isolates. The Clinical Laboratory is supervised by Ms. Juni, M.S., a clinical microbiologist who has extensive epidemiology experience (in-kind). Mr. Boxrud, M.S. supervises the Molecular Laboratory and is responsible for developing and implementing molecular methods for specific diagnostic and research objectives (in-kind). Dr. Joanne Bartkus directs the PHL (in-kind). 2 This past year, Dr. Lexau, who has a doctorate in epidemiology, who had served for 14 years as an ABCs Surveillance Officer, assumed supervision of the ADIC Emerging Infections Unit which includes ABCs, UNEX, and influenza activities. Dr. Lexau also serves on the EIP ABCs Pneumococcal Pathogen Committee. Dr. Lynfield had been the Emerging Infections Unit Supervisor but she assumed the role of MDH Medical Director in addition to State Epidemiologist and had to relinquish that role and reduce some of her responsibilities in the area. Organizational charts are in Attachment 2. II. Need As EIP has matured and grown it has been increasingly difficult to scientifically and adminstratively oversee all programs and activities, administer budgets, write applications and progress reports, prepare IRB applications, maintain essential internal and external partnerships, promote EIP in Minnesota, and fulfill national EIP network responsibilities. We have shifted some responsibilities and spread them to several key persons (Drs. Danila, Smith, Lexau, DeVries, and Ms. Harper; and Lynfield [with her changed responsibilities noted above]). However, we have a need for at least one supervisor to be funded from EIP. Dr. Lexau's appointment to head the Emerging Infections Unit allows this to happen. Since she was previously funded by EIP to be the ABCs Surveillance Officer, we can backfill behind her to fill this position, freeing her to concentrate on overall scientific and administrative oversight of ABCs, UNEX, and influenza surveillance. She has several key long-time staff who will continue to conduct and assist in surveillance and special projects. A key challenge for MDH ABCs that just started in August 2010 is the transfer of ABCs databases and all surveillance management activities to the Minnesota Electronic Disease Surveillance System (MEDSS), a newly developed PHIN-compliant system being developed by a commercial vendor for MDH. A MEDSS tuberculosis module has been successfully adopted and is in use and an influenza module, including for EIP activities, is being finalized for use October 1, 2010. Implementation of MEDSS modules requires an iterative process of information technology (IT) development, testing by Surveillance Officers and others, and directed edits back to the IT developers. Dr. Lexau has been serving on the MEDSS Lead Team and detailed knowledge of transmission of ABCs data to CDC, so will significantly aid in the ABCs transition to MEDSS. In addition, we are proposing to add a Grant Specialist who would be responsible for preparing applications, preparing progress reports, monitoring and adjusting budgets, responding to administative requrests both from CDC and MDH, assisting in preparation of IRB applications and maintaining a file of IRB approvals, and preparing as well as assisting EIP staff in general administartive and clerical duties. As stated, MDH sponsors an annual Emerging Infections Conference. Attendance averages 275, primarily physicians, IPs, microbiologists, and public health staff. We do not accept support from pharmaceutical companies since antimicrobial resistance is an important annual theme. Each year we have had difficulty in securing approximately $15,000 needed to underwrite the conference to continue to keep registration fees low. So, we are requesting $5,000 to help support this important venue to present EIP findings to Minnesota healthcare providers with a 3 focus on implications for practice. III. Operational Plan Once funding is approved, funding for Dr. Lexau's position will be changed, freeing up funds to hire an ABCs surveillance officer. In addition to scientific oversight provided by Drs. Lynfield and Danila, administrative duties will be shared by Drs. Danila, Smith, Lexau, and Ms. Harper. These staff will continue to provide scientific leadership as well. We will hire the Grant Specialist within 3-4 weeks of the funding award. We will transfer funds to the University of Minnesota Department of Continuing Medical Education (UM CME) to support the Emerging Infection Conference. IV.Measures of Effectiveness With Dr. Lexau being appointed Emerging Infections Unit Supervisor her former ABCs Surveillance Officer position will be back-filled by a new epidemiologist by November 2010. The Grant Specialist will be hired and take over EIP administrative duties as described by November 2010. Funds will be transferred to UM CME to support the Emerging Infections Conference. ABCs reports are re-designed for easier use and interpretation by clinicians, infection preventionists, and local public health. 4 Activity 3: Information Technology and Exchange I. Background and Understanding The MDH EIP future progress depends on our infrastructure for receiving, processing, analyzing, and transmitting EIP data. Our current EIP data systems are comprised of individual databases for each disease and sometimes multiple databases for a single disease that are not interoperable. These systems were separately developed and are separately managed. We are able to report case information for EIP diseases to CDC, but this has to occur using multiple mechanisms that are disease-specific. Our current infrastructure is inefficient for reporting because data entry and reporting to CDC is redundant. Reporting EIP pathogen data to hospitals and to local public health is difficult because the data can only be compiled by querying each individual pathogen database. We are not able to append laboratory results onto case reports within pathogen-specific databases. This is a key limitation because all EIP pathogens require additional laboratory testing by the PHL or CDC. This process requires queries by PHL and epidemiology staff and linking with EIP data by methods specific to each program. MDH has invested in a disease surveillance modernization project, including purchase of an electronic disease surveillance system, the Minnesota Electronic Disease Surveillance System (MEDSS). MEDSS will meet Public Health Information Network (PHIN) requirements and will standardize data elements common to case reports of different pathogens. MEDSS is a person- centric system that will replace individual disease databases including across EIP. The MEDSS infrastructure is in place, and work is underway to configure the system for each pathogen. MEDSS also will electronically transmit disease report information to CDC without the need for individual queries or duplicative data entry. In addition, beginning in 2004 and continuing to the present, the PHL has been redeveloping and revising its laboratory information management system (LIMS), with interoperability between LIMS and MEDSS. MDH Information Technology (IT) staff have also increased the capacity to receive and transmit data. MDH is working with health care partners to promote implementation of PHIN-MS to receive secure messages and MDH has implemented Rhapsody to translate messages. II. Need MEDSS is very flexible with relatively easy changes to the configuration of data modeling, workflows, and reporting work assigned, and reports generated. Data management is user- determined not system-determined. However, because the design for each pathogen has few pre- set criteria, the configuration for each disease requires an up-front detailed, time consuming process for epidemiologists and IT staff. Multiple modifications are necessary after initial testing is complete. Much work needs to be done to configure MEDSS to accommodate ABCs and other EIP surveillance, in particular, to make data reported optimally formatted for use by CDC. These areas are especially complicated because each has extensive epidemiologic, clinical, and laboratory data required by CDC. Additionally, by virtue of the fact that these pathogens are emerging and new fields may be required frequently, the configuration must be adaptable and modifiable by users. 5 Because current EIP staff have significant existing workloads, a new staff person is requested to work with MEDSS IT to focus on FoodNet, ABCs and UNEX. This person will work with epidemiology and IT staff to determine business requirements, design the model, perform basic programming tasks, and test the system (including tracking errors and design issues). This person will also act as a super-user to assist EIP program staff in using the new system. As development of both MEDSS and LIMS continues and implementation begins, there is increasing need for laboratory time on this project. Historically, lack of adequate staff has created bottlenecks for the PHL at the points of testing (evaluation of code from developers), resolution of messaging challenges, and user acceptance testing. We are requesting a PHL IT position to continue LIMS development with special focus on creating both test structure and language that are compatible with reporting and messaging requirements of MEDSS, CDC and other partners in order to address these gaps. Angela Jacobsen has significant expertise in IT as well as laboratory training and PHL experience. She understands LIMS and the business needs of the PHL and is well suited to working with other PHL staff during LIMS test design and set- up, user acceptance testing and final training. Her current position is at risk because she is supported by temporary funding. III. Operational Plan Work on MEDSS for EIP pathogens would begin immediately since the infrastructure for the system is already in place. Once hired, the new epidemiologist would first work on the FoodNet and ABCs pathogens, and then on UNEX. The epidemiologist would begin by documenting the business requirements including description of all data fields, modeling of business processes, developing question packages for each disease, working with IT staff to program the MEDSS system for the diseases, testing of modules, debugging, and determining enhancements. Similarly, work on LIMS and its interoperability with MEDSS would begin immediately. Once funding is approved, Ms. Jacobsen will be appointed. Her responsibilities will include identification of business requirements, determination of LIMS test designs and set-up, determination of messaging requirements, and implementation as well as documentation and training. She will work closely with LIMS design staff, MEDSS IT staff and laboratory users. The proposed timeline for the ABCs and UNEX IT infrastructure staff person for the first budget year is: October 2010: Hire epidemiologist and train on MEDSS and MEDSS modeling. They will also work with EIP epidemiologists to gain an understanding of the current process for the ABCs pathogens by reviewing current databases, work flow, and reports. October 2010-January 2011: The epidemiologist will gather business requirements for the FoodNet and ABCs pathogens for review with the EIP epidemiologists. January-March 2011: Epidemiologist will finalize business requirements for the ABCs pathogens and begin modeling diseases including developing question packages for MEDSS. They will also gain an understanding of the current process for UNEX cases by reviewing 6 current databases, work flow, and reports required for the UNEX program. March-May 2011: Epidemiologist will work with IT programmers and epidemiologists to ensure the ABCs pathogens are correctly implemented into MEDSS including the question packages, work flows, and reports. The epidemiologist will test MEDSS for each ABCs pathogen to verify that MEDSS follows the business requirements. The staff person will also gather and finalize business requirements for the UNEX program. May-September 2011: The epidemiologist will finalize implementation of ABCs pathogens into MEDSS and gather suggested enhancements of MEDSS for ABCs pathogens. They will model the UNEX program including developing question packages for MEDSS and working with MEDSS IT staff to program and implement them. The staff person will test the UNEX module to verify MEDSS follows the business requirements. They will finalize implementation of UNEX into MEDSS and gather suggested enhancements of MEDSS for the UNEX program. The proposed timeline for the LIMS laboratorian (Ms. Jacobsen) for the first budget year is: October 2010-January 2011: The person will work with the MEDSS team, and epidemiology and laboratory staff to determine which data fields should reside in MEDSS and which should reside in LIMS. The person will also work with this team to make sure that CDC requirements for data transmission are met. January-March 2011: The laboratorian will gather business requirements (including messaging to MEDSS and reports) for influenza laboratory testing for LIMS. The person also will communicate these requirements to LIMS programming staff. March-May 2011: The laboratorian will work with IT programmers and laboratory staff to ensure that influenza is correctly implemented into LIMS. The staff person will work with epidemiologists and laboratory staff to prioritize implementation of EIP diseases into LIMS. May-September 2011: The laboratorian will train laboratory and epidemiology staff on the influenza module in LIMS. The person will gather business requirements (including messaging to MEDSS and reports) for EIP diseases per the prioritization for implementation in LIMS. The person also will communicate these requirements to LIMS programming staff. IV. Measures of Effectiveness We will measure effectiveness of ABCs and UNEX implementation using the following: 1. FoodNet and ABCs pathogens (100%) are implemented in MEDSS. 2. Data transfer to EIP/ABCs at CDC will be acceptable. 3. UNEX is implemented in MEDSS. 4. Reports on FoodNet and ABCs pathogens and UNEX cases are generated by MEDSS. We will measure the effectiveness of further LIMS development focusing on reporting and messaging requirements using the following: 7 1. Reach a final agreement with the MEDSS team and CDC on data fields to be exchanged. 2. Track the number of laboratory tests set up and ready for implementation into LIMS. 3. Support influenza test orders, laboratory reporting and data exchange by February 2011. 4. Track the number of laboratory staff trained to use the revised LIMS. 8 Activity 4: Enhancement of General Epidemiology and Laboratory Capacity Related to PCR Testing for Influenza, and Healthcare Associated Infections Activity 4a. PCR Testing for Influenza I. Background and Understanding From April 2009-February 2010 the Public Health Laboratory (PHL) analyzed nearly 12,000 samples submitted for influenza testing. Testing was performed by a highly trained team of scientists who shared responsibilities for specimen receipt/processing, analysis by real time PCR, and communicating results to epidemiologists and providers. The PHL has implemented a pyrosequencing method to detect oseltamivir resistance and testing of 2009-10 H1N1 specimens is in progress. PHL responded to the unprecedented volume of testing by enlisting other PHL staff to assist with requests for results, reassigning staff to assist with specimen receipt and problem solving, and adopting an extended day testing schedule. Information Technology staff responded to the need for design of additional data entry fields and expedited fax reporting to submitters. The PHL has since participated in evaluations of the response and recognizes the need to improve communication. PHL also participated in the 510K study to assist with the validation of the CDC's 2009 Influenza Real-Time RT-PCR Panel. II. Need During the 2009-10 influenza pandemic, staff were stressed by the volume of testing, submitters' demands for results, and submitter confusion caused by necessary changes in the testing algorithm. Staff and leadership were concerned about their diversion from other important responsibilities. While we were able to provide results within the desired turn-around-time throughout the response, we were challenged by equipment availability and staff capacity. We propose to add a position to our molecular testing staff to serve as the influenza team lead, coordinating use of the established testing algorithm, expanding the PHL capacity for influenza PCR testing, performing specialized methods for antiviral resistance detection and testing 2009 H1N1 specimens for markers presumptively associated with increased pathogenicity. We plan to test all patients hospitalized with influenza-like illness for influenza and determine the influenza type. A sample will be used for oseltamivir resistance (H275Y) by pyrosequencing. Jason Woton is experienced in advanced molecular techniques. His current position is supported by soon to expire Public Health Emergecny Response funds. III. Operational Plan Once funding is approved, Mr. Woton's position will be changed. MDH influenza response will improve with the addition of this PCR testing capacity and additional coordination of influenza testing algorithm. PHL will continue to perform and add, as appropriate, molecular tests to characterize antiviral resistance (pyrosequencing to detect the H275Y mutation) and markers presumptively related to viral pathogenicity such as D222G. The following improvements will be more easily accomplished with the added laboratory capacity. Submitters will receive clear information on testing criteria and specimen 9 requirements. Laboratory training on new testing methodology will take place and staff competency established. Surveillance data needs and reporting mechanisms will be identified and addressed. IV. Measures of Effectiveness PHL will measure the effectiveness of this plan by: Monitoring the number of rejected specimens caused by noncompliance with acceptance criteria. Monitoring the number and types of submitter calls received and answered. Monitoring and communicating testing volume. Establishing and monitoring test turn-around-times. 10 Activity 4 b. Healthcare Associated Infections I. Background and Understanding MDH has conducted surveillance for multi-drug resistant organisms (MDRO) including invasive methicillin-resistant Staphylococcus aureus (MRSA) since 2004, Clostridium difficile infection (CDI) since 2009, and highly resistant gram-negative organisms since 2009. MDH initiated a statewide approach to health-care associated infection (HAI) prevention through the development of an HAI Advisory Group, state HAI plan, and two HAI prevention collaboratives (CDI and surgical site infection). MDH is collaborating with CDC and other EIP sites to conduct a HAI point prevalence survey, a healthcare-associated community-onset (HACO)-MRSA project, a multistate gram-negative surveillance initiative, a National Healthcare Safety Network (NHSN) denominator simplification project, and expanded population-based CDI surveillance. Statewide HAI reporting requires acute care facilities to use National Quality Forum measures to report ventilator-associated pneumonia bundle, central line, and surgical site infection measures to the Minnesota Hospital Association. Dialysis centers are not required to publicly report infections. The majority of patients on maintenance hemodialysis are treated in free-standing outpatient facilities. These centers typically do not have on-site infection expertise, yet these patients are vulnerable to infection due to their underlying health conditions, the invasiveness of dialysis and exposure to other patients in dialysis centers. Blood stream infections (BSI) represent a substantial cause of morbidity and mortality in dialysis patients and hospitalization rates due to BSI increased 31% since 1993. In Minnesota, 4/8 reported vancomycin-intermediate S. aureus (VISA) cases and nearly 20% of HACO-MRSA cases received dialysis in the year prior to infection onset. A relationship between MDH and dialysis centers will allow MDH to more accurately estimate the true burden of HAI among dialysis patients. MDH recognizes the need to develop approaches for standardized case finding and metrics, simplified infection detection and reporting, and enhanced infection prevention training for dialysis centers. This information will inform and drive interventions that ultimately will result in the reduction of BSI and other HAI in this population. MDH has a long-standing relationship with the Association for Professionals in Infection Control and Epidemiology-Minnesota Chapter (APIC-MN), North Central Chapter of Infectious Diseases Society of America, and the Minnesota Antibiotic Resistance Collaborative. MDH has extensive experience entering into contracts to further CDC Cooperative Agreement objectives, to promote educational programming (APIC-MN) and support dev...